Mechanisms by which the ketone body β-hydroxybutyrate counteracts tau pathogenesis

PROJECT SUMMARY/ABSTRACT
The ketogenic diet has been proposed as a treatment for Alzheimer’s disease (AD), a disease marked by the
aggregation and inter-neuronal spreading of the protein tau. Although preclinical studies and early stage
clinical trials have shown promising results on improved memory in individuals with early AD, the
mechanism(s) by which the ketogenic diet slows AD progression is not well understood. Such gap of
knowledge prevents the development of more precise ketone-based therapies with higher efficacy and reduce
side effects. The ketogenic diet might act through multiple mechanisms: for example, the main ketone body, β-
hydroxybutyrate (BHB), provides an energy source and also acts as a signaling molecule. Parsing the
contribution of these mechanisms will help define which components of ketogenic diet are most relevant to
tauopathies. We have found that a ketone-supplemented diet significantly reduced tau spread in mice.
Additionally, treatment with BHB markedly reduced tau secretion in cultured cortical neurons. The overall
objectives in this application are to elucidate the cellular and molecular mechanism(s) by which BHB reduces
tau spread and neurodegeneration. The central hypothesis is that BHB acts to inhibit tau spread primarily via
its signaling activity, and specifically, BHB represses tau secretion from neurons and promotes its degradation
through the autophagic-endolysosomal flux. The rationale for this project is that a determination of the
preclinical therapeutic efficacy and mechanism(s) of BHB on tau spread will likely lead to better targeted and
more effective ketone-based pharmacological therapies for AD and other tauopathies. The central hypothesis
will be tested by pursuing three specific aims: 1) Determine the contribution of signaling verses bioenergetic
activity of BHB in reducing tau spread and improving neurodegenerative phenotypes in mice; 2) Determine the
effects of BHB on the autophagy-endolysosomal pathway (ALP) in regulation of tau degradation, secretion and
propagation, and 3) Determine the impact of BHB on the tau interactome in response to BHB’s signaling and
bioenergetic activity, respectively. The proposed research is innovative because it tackles the unknown
mechanisms underlying the effects of the ketogenic diet on tau, using a combination of pharmacology,
genetics, cell biology and system biology approaches in primary and iPSC-induced neuronal culture, fly and
mouse models. Results from the proposed studies will bridge the knowledge gap of how the ketone body
affects tau pathogenesis and elucidate the underlying mechanisms, thus enable future development of novel
treatment strategies for AD and other tauopathies.

Public health relevance
PROJECT NARRATIVE Ketogenic diets are being investigated in the treatment of Alzheimer’s disease, but their mechanism of action is unknown. Given that spread of the tangle-forming protein tau among nerve cells is a key pathological event in Alzheimer’s disease, this project aims to understand how the ketone body β-hydroxybutyrate reduces tau spread in the brain. Successful execution of the proposed research will provide the mechanistic basis for prevention and treatment of Alzheimer’s disease and related dementia through improved ketone-based therapies.